Insight Into The RNA Processing And Decay Pathways Critical For Proper Neuronal Development And Function Through Focus On Mutations That Cause Pontocerebellar Hypoplasia

Project Summary for NOT-GM-21-028 (PA-20-272) supplemental application included in Research Strategy Section.

Public health relevance
Project Narrative not required for NOT-GM-21-028 (PA-20-272) supplemental application.